Use of senolytics to enhance chemotherapeutic efficacy in lung cancer

Project Summary/Abstract:
Chemotherapy and radiation often induce lung cancers to enter a prolonged state of growth arrest with
characteristics of senescence. A senescence-like state is also characteristic of residual tumor cells that survive
after chemotherapy and/or radiation have eliminated the bulk of a tumor cell population. Tumor cells surviving
therapy-induced senescence (TIS) have the capacity to recover proliferative capacity subsequent to their
prolonged growth arrest. Recovery and re-emergence of tumor cells from this growtharrested state could
contribute to disease recurrence months or years after the patient has apparently been cured of the primary
disease. A number of agents have recently been identified as having senolytic properties. Given that disease
recurrence and consequent cancer mortality is frequently associated with the re-emergence of proliferative
tumor cells either at the primary disease site or metastatic sites, a primary goal of this project will be to test the
hypothesis that senolytic agents can eliminate senescent-like lung tumor cells in order to prevent, or at least
significantly suppress, cancer recurrence. Aim 1 will examine the hypothesis that senolytic agents such as the
pro-survival BCL-2 family inhibitor ABT-263 will selectively eliminate cells in the senescence-like state. To this
end, we will perform sorting to isolate exclusively senescent human and mouse non-small cell lung cancer
(NSCLC) cells induced by clinically relevant therapies and establish their sensitivity to senolytic treatment. We
will also determine whether sensitivity to senolytics is altered during the course of senescence, and whether
residual populations surviving after the bulk of the tumor population has been eliminated by therapeutic agents
specifically demonstrate susceptibility to the cell killing effects of senolytics. Finally, ex vivo studies will
determine the ability to TIS cells to induce antigen cross presentation and CD8 T cell priming in the absence
and presence of ABT-263. Aim 2 will determine the mechanisms of apoptosis induced by ABT-263 in TIS cells.
We will examine the role of pro-survival BCL-XL and/or BCL-W as targets of ABT-263, evaluate the interaction
among the BCL-2 family proteins and determine whether p53 is required for sensitization to apoptotic cell
death in TIS cells. Aim 3 will examine the hypothesis that senolytic agents such as ABT-263 will enhance the
response to chemotherapy and/or radiation in both immune-deficient and immune-competent mouse models.
To test this hypothesis we will use the mouse Lewis lung cancer NSCLC tumor model to: (i) study how the
immune system responds to TIS cells; (ii) determine a tolerated dosing schedule for primary therapies to
induce senescence followed by senolytic treatment; (iii) determine how senolytic agents alter the cell non-
autonomous response to chemotherapy and radiation. The sum of these experiments will (i) establish the
involvement of cell non-autonomous responses to tumor cell senescence induced by chemotherapy and
radiation in the absence and presence of senolytic agents; and (ii) establish a therapeutic strategy for the
elimination of NSCLC cells that have the potential to contribute to recurrent disease.

Public health relevance
Parent Grant Project Narrative: This project is designed to address the problem of cancer recurrence by evaluating the capacity of senolytic agents to eliminate non-small cell lung cancer cells induced into senescence by chemotherapy and radiation. Studies both in cell culture and in tumor bearing animals will also identify the contribution(s) of the immune system to the effectiveness of this therapeutic strategy.